Novel AAV Capsids and Gene Regulatory Elements for GeneExpression in Microglia

Project Summary:
Microglia, the resident macrophages of the brain, assume a multitude of functions during brain development and
disease. Long known to react to changes in brains affected by Alzheimer’s disease (AD), genetic studies of late-
onset AD indicate that AD risk variants are commonly found in or near genes that are specifically expressed in
microglia, suggesting that microglia play an active role in driving AD. In addition, microglia exhibit various
functions during brain development, including synapse pruning. Genes coding for components of the
complement system, which mediates synapse pruning by microglia, have been linked to schizophrenia.
However, a major bottleneck in studying the roles of microglia in normal and diseased brains is the lack of viral
tools for rapidly manipulating their gene expression. Viral vectors would also benefit studies where transgenic
animals are not available. Finally, viral vectors would enable studies on the potential of gene therapy for AD and
rare diseases that affect microglia. However, while microglia show modest and localized transduction by
lentiviruses in vivo, they are resistant to transduction by adeno-associated viruses (AAVs), the preferred viral
vectors used in neuroscience research and gene therapy due to their superior spread and excellent safety profile.
Here we propose to elucidate the barriers to microglia transduction by AAVs, engineer AAV capsid variants that
are able to overcome these barriers and transduce microglia in vivo, and develop novel gene regulatory elements
that will enable microglia-specific transgene expression from viral vectors. This will be a collaborative project
between the Stevens and Deverman labs, combining their expertise in studying microglia (Stevens) and in
developing novel AAV vectors (Deverman).

Public health relevance
Project Narrative: This project aims to elucidate the barriers to microglia transduction by AAVs, engineer AAV capsid variants that are able to overcome these barriers and transduce microglia in vivo, and test novel gene regulatory elements that will enable microglia-specific transgene expression from viral vectors. Accomplishing this objective would provide the neuroscience community with tools for rapidly manipulating gene expression in microglia across species. Moreover, microglia-targeting AAVs will enable studies on the potential of gene therapy for diseases that affect microglia.